The Johns Hopkins Nursing Science Incubator for Systemic Solutions (N-SISS): Preparing Innovators to Address the Conditions of Daily Living and Redesign Health

The Nursing Science Incubator for Systemic Solutions (N-SISS) at the Johns Hopkins School of Nursing
will support nurse scientists and scientists in aligned fields in developing innovative and rigorous
programs of research focused on addressing health system gaps and the conditions of daily living.
Because we intend to deliver N-SISS educational materials to two important but distinct audiences—that
is, three annual cohorts of 10 core N-SISS Innovators as well as a national audience of nursing or aligned
researchers and students (ancillary N-SISS network trainees)—we organized the N-SISS program into
two tailored sets of activities and resources. At its core, the program will consist of a 10-month-long
structured training curriculum of individualized research training, applied, hands-on, mentored research
experiences, scientific mentoring, and career support, which will be offered to core N-SISS Innovators
and which will culminate in the submission of an NIH (R, K, or F) grant proposal at the end of the
program. Secondarily, the ancillary N-SISS network trainee program will provide a variety of training
resources for self-directed learning via a dedicated web platform open to all researchers and students at no
cost. The N-SISS program design is innovative in several respects: the curriculum draws upon the project
team's integrated conceptual framework to provide the requisite theoretical and methodological skills to
address health system gaps and the conditions for daily living; the program uses a three-pronged
mentoring approach grounded in the literature of effective scientific and career mentoring for independent
research; and the didactic and collaborative learning opportunities are additive, providing flexibility and
enhancing the reach to national audiences. Program materials and events will be accessible to ancillary NSISS
network trainees, who include members of the broader nursing and aligned scientific workforce (we
estimate at least n=3,600 ancillary network trainees will use the program over the project period). N-SISS
will leverage Johns Hopkins University's extensive research and training infrastructure and the program
directors' national network of researchers committed to addressing health system gaps and the conditions
of daily living to strengthen the scientific nursing workforce's capacity to conduct impactful, innovative
research to redesign health.

Public health relevance
Project Narrative The Nursing Science Incubator for Systemic Solutions (N-SISS) at the Johns Hopkins School of Nursing (JHSON) will support nurse scientists and scientists in aligned fields with developing impactful research programs focused on addressing health system gaps and the conditions of daily living through a novel course designed to prepare Innovators in the (1) implementation of a new dynamic conceptual approaches; (2) application of rigorous research methods; and (3) effective translation of knowledge and skills into the development and dissemination of multilevel interventions that address health system gaps and the conditions of daily living. To promote scientific workforce development, NSISS will implement a two- tiered training approach: three annual cohorts of 10 N-SISS Innovators will receive 10 months of in-depth mentoring, conceptual, and methodological training and applied, hands-on, mentored research experiences culminating in the submission of an NIH (R, K, or F) grant proposal, while the program materials and events will also be made openly available online to all researchers and students who are interested in becoming ancillary N-SISS network trainees (we estimate at least n=3,600 ancillary network trainees will use the program over the project period). In sum, N-SISS will leverage Johns Hopkins University's extensive research and training infrastructure as well as the program directors' national network of researchers committed to addressing health system gaps and the conditions of daily living to strengthen the scientific nursing workforce's capacity to conduct impactful, innovative research to redesign health.